Role of tonic outer hair cell motility in cochlear amplification

PROJECT SUMMARY/ABSTRACT
Mammalian hearing sensitivity depends on outer hair cells (OHCs), which change length and generate force to
amplify sound-evoked vibrations within the cochlea. While it is often assumed that amplification depends on
cycle-by-cycle OHC motility, the ability of this mechanism to operate at sufficiently high frequencies in vivo has
been questioned, and exactly how OHCs interact with the surrounding organ of Corti structures to produce
amplification remains unclear. Clarifying how OHCs work is critical to understanding and restoring what is
missing in ears with OHC damage, which is a common cause of hearing loss. As a step toward this, the
proposed work will determine whether, in addition to fast, cycle-by-cycle length changes, OHCs undergo
sustained, tonic length changes during sound stimulation. Such tonic motility may play a vital, unrecognized
role in the amplification process if it is associated with changes in the organ of Corti’s geometry and
mechanical properties. The proposed work will specifically test the hypothesis that sound elicits tonic OHC
motility via the same electromotile process that drives cycle-by-cycle motility, and that this tonic motility
influences cochlear amplification via changes in the stiffness of the organ of Corti. This hypothesis will be
tested by using an optical coherence tomography-based approach to measure vibrations from within the intact
mouse cochlea in vivo. Aim 1 will fully characterize the tonic, sound-evoked deformations of the organ of Corti
as a function of stimulus frequency and level. If the hypothesis is correct, the top and bottom of the OHC region
will tonically move in opposite directions during sound stimulation. Aim 2 will determine whether this tonic
motility requires prestin (the motor protein that underlies cycle-by-cycle OHC motility) and normal
mechanotransduction, which is needed to produce the receptor potential that drives prestin. This will be tested
by measuring vibrations in mutant mice with abnormal prestin or impaired mechanotransduction. If the
hypothesis is true, tonic motility will be reduced or absent in these mice. Aim 3 will assess whether tonic OHC
motility influences cochlear amplification via associated changes in organ of Corti stiffness. This will be tested
by presenting a very low frequency tone to slowly modulate OHC length and stiffness, and assessing changes
in the organ’s frequency response over time. If the hypothesis is correct, slow OHC length changes will be
associated with specific shifts in the organ’s frequency response. Pursuit of these aims may reveal novel OHC
mechanisms for adjusting the frequency-tuning and gain of cochlear amplification, and thus challenge the
current view of how amplification works. Ultimately, the knowledge gained could inform the design of future,
biologically-inspired rehabilitative prosthetics as well as regenerative approaches to restoring hearing.

Public health relevance
PROJECT NARRATIVE Normal hearing depends on force generation by sensory cells within the organ of Corti. The goal of this project is to determine whether this force generation causes sustained changes in the organ’s geometry and mechanical properties during acoustic stimulation, as these changes could regulate how the organ vibrates in response to different sounds. The knowledge gained will clarify how healthy ears work, as well as what is missing in impaired ears, and will ultimately improve our ability to rehabilitate hearing loss.